A Preconception Cohort Study on Oil and Gas Development, Fertility, and Pregnancy

PROJECT SUMMARY
Over 17.6 million North Americans live within 1.6km of an oil and gas development (OGD) facility. Recent studies
indicate that OGD results in the release of reproductive toxicants (e.g., particulate matter, volatile organic
compounds [VOCs], polycyclic aromatic hydrocarbons [PAHs]) at levels that may harm human health, including
fertility, early pregnancy loss, pregnancy-related disorders, and birth outcomes. Epidemiologic studies on OGD
to date have largely focused on live birth outcomes, have not included personal exposure measurements, and
have little data on key confounders. Building upon data analysis from an NIEHS-funded predoctoral fellowship
(F31-ES029801) and training in prospective cohort designs in her postdoctoral research, Dr. Mary Willis’ Early
Independence Award application launches the first prospective cohort study on OGD-related pollution and
reproductive health. This proposal leverages ongoing recruitment from the Pregnancy Study Online (PRESTO,
R01-HD086742), an internet-based preconception cohort study of North American couples trying to conceive
(n>16,000 female participants), to examine the influence of OGD-related exposures on reproductive health. This
cohort has remarkable geographic diversity, spanning all 50 U.S. states and all 10 Canadian provinces. To date,
>4,500 of the women reside in communities with OGD activity and this application will use geo-targeted methods
to enroll an additional 1,000 women. Aim 1 develops OGD-related exposure metrics in the PRESTO cohort, an
extension of Dr. Willis’ previous work. Exposure assessment methods include 1a) complex spatial data
integration of industry-related information that spans back to participants’ own births, 1b) a supplemental
questionnaire of perceived risks about OGD, and 1c) personal exposures to air, water, and noise in a subset of
150 women at three time points in the preconception to early pregnancy periods. All exposure assessment
methods are validated, state-of-the-art approaches. Aim 2 applies these exposure metrics in a longitudinal
framework to examine the influence of OGD on important reproductive health outcomes in the full PRESTO
cohort. Outcomes include 2a) fertility (fecundability, the per-cycle probability of pregnancy), 2b) pregnancy loss
(spontaneous abortion), 2c) pregnancy-related hypertensive and metabolic disorders (gestational hypertension,
pre-eclampsia, gestational diabetes), and 2d) birth outcomes (preterm birth, low birth weight.) The aims set the
stage for a “Research to Action” proposal that explores the efficacy of personal or community interventions for
specific OGD exposures, as well as the groundwork for an R01 proposal with follow-up for maternal postpartum
health and child development. By leveraging an established internet-based prospective cohort study, this
proposal addresses the logistical challenges of efficiently assessing the influence of health effects of emerging
environmental hazards. The results of this project have high potential to improve public health by demonstrating
a novel policy-relevant framework to investigate emerging environmental hazards. This award will allow Dr. Willis
to launch her career at the intersection of environmental epidemiology, data science, and reproductive health.

Public health relevance
PROJECT NARRATIVE Activities related to the oil and gas industry release environmental contaminants, including reproductive toxicants, that may adversely affect fertility, pregnancy, and birth. Using multiple exposure measurement techniques (spatial data integration, risk perceptions, and primary exposure data collection), the proposed research will examine the influence of oil and gas development on reproductive health.